Molecular mechanism for pharmacological activation of KCa2 channels

ABSTRACT
Small-conductance Ca2+-activated K+ channels, KCa2 (also called SK), are important for regulating neuronal
excitability in the central nervous system. These channels are gated by a Ca2+/calmodulin (CaM)-mediated
mechanism. Small molecule KCa2 activators are highly sought-after as potential therapeutics for substance use
disorders, cerebellar ataxia, and essential tremor.
Based on our recent pharmacological studies, we propose the recategorization of KCa2 activators into two groups,
classic positive allosteric modulators (PAMs) and superagonists. CyPPA was the first classic PAM described to
positively modulate KCa2.2 and KCa2.3 channels, while being inactive on KCa2.1 and KCa3.1. We have developed
novel, subtype-selective classic PAMs of KCa2.2 and KCa2.3, respectively. Superagonism has not been observed
with these classic PAMs. NS309 was initially the most potent activator of KCa2 and KCa3.1 channels. We have
developed a more drug-like compound, SKA-31, which potentiates both KCa2 and KCa3.1, and a subtype-selective
KCa3.1 activator SKA-111. We discovered that this group of activators can produce maximal responses greater
than the endogenous agonist (Ca2+) for the KCa2 and KCa3.1 channels and renamed them superagonists.
In Aim 1, we will compare the mechanisms of action for the classic PAMs and superagonists of KCa2. We will
define the interactions of classic PAMs and superagonists with KCa2 channels. We will compare the mechanisms
of superagonism versus classic positive allosteric modulation.
In Aim 2, we will search for novel KCa2 activators using both virtual high-throughput screening and Artificial
Intelligence/Machine Learning approaches, followed by experimental testing using electrophysiology assays to
determine their potency and selectivity. We will evaluate the efficacy of the most potent and selective classic
PAMs and superagonists to rescue pathogenic loss-of-function KCa2.2 mutants. Loss-of-function KCa2.2
mutations are associated with neurodevelopmental disorders including cerebellar ataxia and tremor in humans.

Public health relevance
NARRATIVE Small-conductance Ca2+-activated K+ channels (KCa2) play an important role in controlling neuronal excitability in the brain. We propose the recategorization of the KCa2 activators into two groups, superagonists and classic positive allosteric modulators, based on their differential mechanisms of action. We will search for novel KCa2 activators using virtual high-throughput screening and Artificial Intelligence/Machine Learning approaches for the treatment of substance use disorders, cerebellar ataxia, and essential tremor.